Defining Quality of Care in Lung Cancer

Background: Non-small cell lung cancer (NSCLC) is the leading cause of cancer-related mortality in Veterans.
With the implementation of computed tomography screening, the incidence of Stage I lung cancer (tumors less
than 5 cm with no metastases) is increasing exponentially in Veterans. Stage I NSCLC is potentially curable with
surgery as the recognized gold standard of therapy. Wide variations exist in the care of Veterans with lung
cancer. These inconsistencies in care are directly linked to suboptimal short- and long-term outcomes. Lack of
clear guidelines is an important determinant of variable care. A number of national organizations have proposed
quality measures (QMs) for surgery in lung cancer. However, these measures have largely been developed
based upon retrospective institutional studies or expert opinion. A lack of evidence-based, validated QMs
remains a critical unmet need. To address this crucial gap in knowledge, we will use the large, prospectively
maintained Veterans Health Administration (VHA) database. The goal of this proposal is to develop a model to
define high-quality surgical care for lung cancer and understand factors impacting quality of surgery.
Significance: By creating a model of high-quality surgery for lung cancer, relevant to Veterans and the general
population, our proposal directly addresses the Department of Veterans Affairs (VA) priorities of quality of care
and transforming VA data into a national treasure. The recently launched VA-Partnership to increase Access to
Lung Screening aims to detect 80% of all lung cancers at a curable stage. Our study focuses on optimal therapy
for early-stage lung cancer, a current and, even more importantly, future imperative for the Veteran population.
Innovation: Our proposal is innovative both conceptually and technically. The conceptual innovation relates to
the holistic consideration of modifiable variables to define and impact high quality healthcare. The technical
innovation relates to the implementation of a unique approach utilizing a prospectively maintained dataset for
model development and validation.
Specific Aims: Aim 1. To identify model-based quality measures for surgery in lung cancer and determine which
have the greatest impact on short, and long-term outcomes. We hypothesize that among the candidate QMs,
our models will identify key measures that are associated with improved short-term outcomes (operative
morbidity and mortality) and long-term survival. Aim 2. To evaluate adherence to quality measures for surgery
and understand the contribution of geographic, patient-, disease-, and treatment-related factors in adherence to
quality measures for surgery in lung cancer. We hypothesize that younger, white patients, with smaller tumors,
treated at urban facilities will be associated with meeting QMs for surgery in lung cancer.
Methodology: In Aim 1, utilizing the VHA database, we will examine the relationship between adherence to
previously proposed (e.g. type of operation, extent of nodal sampling) as well as novel (e.g. delay in surgery)
QMs for surgery and short-term outcomes (postoperative complications, 30-day mortality) and long-term survival
using regression models. The relative importance of the QMs will be assessed by rank ordering.
In Aim 2, we will develop a weighted, validated QM adherence score ranging from 0 (no adherence to QMs) to
100 (complete adherence to QMs) for lung cancer operations. We will evaluate geographic (e.g. urban versus
rural), patient (race, comorbidities), disease (e.g. tumor size), and treatment (e.g. facility size) factors associated
with adherence to QMs.
Next Steps/Implementation: Our study will define “what constitutes a high-quality lung cancer operation”. For
the next logical step of “how to optimize the likelihood of a high-quality operation”, we will propose interventions
addressing important QMs with input from the results of our study and the advisory board, which represents
expertise in lung cancer, health policy, and implementation science. These interventions will be refined and pilot-
tested in our VISN 15 in a future study before being nominated for policy change at the national level.

Public health relevance
Lung cancer is the leading cause of cancer-related mortality in Veterans. With higher prevalence of smoking, lung cancer incidence rates remain significantly higher in Veterans compared to the general population. Due to the advent of successful Computed Tomography screening, lung cancer is increasingly being diagnosed at an early stage. Surgery is the gold standard for treating early-stage lung cancer, however, wide variations in surgical care are associated with suboptimal outcomes. An important reason for these inconsistencies in care is the lack of consensus regarding components of a high quality operation. In this proposal, using the Veterans Health Administration database, we will address this critical gap in knowledge by validating quality measures for surgery in lung cancer, and outlining factors that lead to high quality operations. Our proposal will create a benchmark for quality of surgery in lung cancer thereby allowing targeted interventions to improve the quality of care especially in the Veteran population.